The design and evaluation of strategies to implement HIV prevention interventions for pregnant women in community pharmacy settings

PROJECT SUMMARY: Pregnant women in high HIV-burden settings such as western Kenya are at increased
risk of acquiring HIV infection during pregnancy. The World Health Organization (WHO) and Ministry of Health
in Kenya recommend a comprehensive HIV prevention package for pregnant women in high HIV-burden settings
including oral pre-exposure prophylaxis (PrEP), STI screening and treatment, and partner testing. However, poor
utilization of antenatal care limits opportunities for timely identification and delivery of HIV prevention
interventions. In Kenya, community pharmacies are often the first point of contact for basic health services and
an important entryway for reproductive health services. Leveraging existing structures, such as community
pharmacies, can create cost-efficient opportunities for improving access to HIV prevention interventions among
pregnant women. However, it is unclear which combination of interventions would best satisfy pregnant women’s
needs and optimize uptake, which strategies should be used for implementation, and the cost of extending
implementation of these interventions to community pharmacy settings. The overall objective of this study is to
design and evaluate strategies to implement HIV prevention interventions for pregnant women in community
pharmacy settings. In Aim 1, we propose to conduct a discrete choice experiment to quantify preferences for
delivery of HIV prevention interventions (including PrEP, STI screening and treatment, and partner testing) for
pregnant women in community pharmacy settings. Latent class analysis will be used to quantify women’s stated
preferences and identify packages of intervention components that optimize uptake among different subgroups
of women. In Aim 2, we will identify provider- and system-level factors that might influence implementation of the
optimal intervention packages and select strategies to improve implementation. Finally, in Aim 3, we will evaluate
the potential costs of extending implementation of HIV prevention interventions from the clinic to community
pharmacy settings under a range of different intervention packages (Aim 1) and implementation strategies (Aim
2). The proposed research aims complement my training goals in (1) community-based model design for HIV
prevention intervention delivery, (2) stated-preference theory and methods and the application of discrete-choice
experiments, (3) implementation science, and, in particular, implementation strategy design, and (4) advanced
costing methods and their application to costing implementation strategies. Successful completion of these aims
will enable me, as part of a future R01, to pilot test and assess the acceptability, feasibility, and impact of a
pharmacy-based model for delivering HIV prevention interventions to pregnant women. My long-term goal is to
become an independent implementation scientist and design new models of care to implement and scale HIV
prevention interventions for pregnant women. Alongside outstanding expertise from an interdisciplinary
mentoring team and the excellent training and research environment at The University of Washington, this career
development award provides a solid foundation for me to launch my career as an independent researcher.

Public health relevance
Project Narrative Community pharmacies play an important role in the health care system: they are frequently accessed and have increasing capacity to deliver HIV prevention services. In communities where the prevalence of HIV is high and access to antenatal care clinics is delayed or infrequent, there is a unique opportunity to leverage pharmacies to enhance early and sustained access to HIV prevention among pregnant women. This study will identify women’s preferences for delivery of HIV prevention services and provider-level and system-level strategies to design a new pharmacy-based model of care for pregnant women.